Ultrasensitive multiomic platform using epitope-targeted DNA methylation mapping

Candidate Eligibility Statement
The goal of this diversity supplement application is to provide career development support for Dr. Allison
Hickman, a bioinformatician who aspires to (and with support could perform) leadership roles in commercial
science. Women have been under-represented in science leadership, particularly in the field of bioinformatics,
and this award would formally address the issue by supporting a truly talented individual. Dr. Hickman is a US
citizen and full-time employee at EpiCypher Inc., a Small Business Concern (SBC) eligible to submit applications
to the National Institutes of Health. EpiCypher was recently awarded an SBIR Fast-Track Grant from NHGRI
[R44 HG011875] that is currently in year one (of three) and is eligible for diversity supplement support.
5.12.2022
Dr. Allison Hickman - Diversity Supplement Candidate (Research Scientist) Date
5.11.2022
Dr. Martis Cowles - EpiCypher Signing Official (Chief Business Officer) Date

Public health relevance
This section is not applicable per the funding opportunity announcement. ASSIST required a document be uploaded to pass system validations.